Roles for SGK1 in Cardiometabolic Heart Failure with Preserved Ejection Fraction

Project Summary:
Heart failure with preserved ejection fraction (HFpEF) has emerged as the greatest unmet medical need in
cardiovascular medicine, comprising 50% of all HF cases, with a US prevalence of ³3 million. HFpEF is
associated with high morbidity and mortality, with a 5-year survival after hospitalization worse than most cancers
of ~35% and, unlike the better understood heart failure with reduced ejected fraction (HFrEF), there are no
evidence-based therapies for HFpEF. HFpEF represents an entirely new disease threat because of the systemic
metabolic and endocrine nature of its pathogenesis. And, while HFpEF is heterogeneous in its clinical
presentation, arguably the most prevalent form is cardiometabolic HFpEF (cMet HFpEF), where the main
comorbidities are obesity, type 2 diabetes, and hypertension. These same comorbidities are the major drivers of
concomitant obesity-related diseases that includes nonalcoholic fatty liver disease (NAFLD), which is prevalent
in more than 50% of HFpEF patients and has been demonstrated to be an independent predictor of all-cause
mortality in HFpEF. This is of unique concern as the obesity epidemic continues to grow with current estimations
that 45% of the world’s population is either overweight or obese. Our preliminary data support the notion that the
heart is a primary regulator of global metabolic syndrome through the serine-threonine kinase, serum
glucocorticoid kinase 1 (SGK1). Global SGK1 overexpression has been demonstrated to promote increased
obesity, dyslipidemia, while liver-specific deletion of SGK1 has been shown to protect against NAFLD. While
there is a clear connection between SGK1 and obesity-related metabolic syndrome, neither a role for SGK1 in
cMet HFpEF nor the mechanism by which SGK1 regulates cellular metabolism have been investigated. In this
proposal, we will focus on cardiac-specific SGK1 in cMet HFpEF with the hypothesis that SGK1 promotes
increased mTORC1 activity in the heart via phosphorylating PRAS40 which exacerbates cardiac pathology and
subsequent global metabolic dysfunction in cMet HFpEF. We will address this hypothesis using cardiac-specific
targeting of SGK1 and PRAS40 in a mouse model of cMet HFpEF with a focus on assessments of cardiac
function and metabolism, as well as mechanistic studies in primary cardiomyocytes, in the following Specific
Aims which are to: (Aim 1) determine the role for cardiac SGK1-PRAS40 signaling in regulating heart function,
metabolism, and heart directed inter-organ communication during cMet HFpEF, (Aim 2) determine whether
PRAS40 inhibition by SGK1 promotes mTORC1 mediated pathologic cardiac metabolic inflexibility during cMet
HFpEF, and (Aim 3) evaluate the therapeutic efficacy of a novel SGK1 inhibitory peptide for preserving cardiac
function and systemic metabolism during cMet HFpEF. These studies are significant as the present the
opportunity to identify novel secreted factors from the heart that regulate global metabolic health as well as to
test new therapeutic targets for both HFpEF and obesity-related diseases.

Public health relevance
Project Narrative Cardiovascular disease accounts for 1 in every 3 deaths in the US, typically as a result of pathological cardiac remodeling and subsequent heart failure, for which there is no cure. As the percentage of obese individuals continues to grow at an alarming rate, coming to the forefront in cardiovascular medicine is that the pathophysiology of the majority of heart failure patients involves a multi-organ syndrome in which cardiac, inflammatory, metabolic and other systems result in the diagnosis of what has been recently coined heart failure with preserved ejection fraction (HFpEF). The studies proposed here aim to decipher the molecular mechanisms contributing to HFpEF, with the anticipation that understanding these mechanisms will help us to develop novel and selective therapeutic avenues for intervention and, thus, reduce mortality from this form of cardiovascular disease and associated obesity-related diseases.